Designing Ligand Platforms of Titanium Imido Catalysts and Statistically Screening Alkyne Substrates for [2+2+1] Regioselective Pyrrole Synthesis

Project Summary/Abstract
Substituted pyrroles are pivotal organic building blocks in pharmaceuticals, materials, and natural
products, however, these scaffolds are often difficult targets. Recently, a titanium imido complex was
found to be effective in catalyzing [2+2+1] synthesis of pyrroles using simple alkyne and diazene
starting materials. This three-component oxidative coupling offers a new methodology for catalytic
pyrrole synthesis and has the potential to be a valuable synthetic tool for organic synthesis of
pharmaceuticals and natural products containing a pyrrole core. This research proposal seeks to
expand this work by improving regioselective synthesis of pyrroles via catalyst control and to improve
rates of reaction by tuning electronic properties of ancillary ligands by modulating arylchalcogenides.
In addition, dinitrogen will also be utilized as a new nitrogen source for pyrrole synthesis.

Public health relevance
Project Narrative Substituted pyrroles are pivotal building blocks in pharmaceuticals and natural products, however, the synthesis of these molecules typically require arduous, stepwise organic syntheses. This titanium catalyzed pyrrole synthesis offers new strategies to effectively synthesize difficult to obtain pyrrole building blocks. New generations of titanium catalysts are being developed to offer control over the regiochemistry of these pyrrole products that will provide practical synthetic methodologies for pharmaceutical and natural product synthesis.